Liver Cirrhosis Network: Scientific and Data Coordination Center

PROJECT SUMMARY
Liver cirrhosis poses a significant public health burden in the United States (US) as it is associated with
substantial morbidity, mortality and cost. An estimated one-third of patients develop decompensating events
such as gastrointestinal variceal bleeding, ascites, hepatic encephalopathy (HE), jaundice, and renal impairment.
Further, these poor outcomes are also associated with development of hepatocellular carcinoma (HCC) in the
cirrhotic liver, the ninth leading cause of death among cancers within the US. While transplantation is a curative
treatment for cirrhosis, patients are often ineligible for transplantation due to lack of available organs and
additional risks involved. Thus, patients and providers frequently focus on symptomatic treatment options such
as lifestyle/nutrition modifications to initiate weight loss and optimize protein absorption, nonselective beta-
blockers to reduce the risk of gastrointestinal bleeding, and treatment for HE to improve confusion. A recent
meta-analysis suggests statin therapy as a promising treatment for cirrhosis as statins tend to decrease oxidative
stress and inflammation and increase endothelial cell function, with downstream effects including reduction of
hepatic inflammation, fibrosis, and vascular tone. Although this review represents over 120 thousand patients,
true efficacy data in the setting of a randomized controlled trial (RCT) are presently limited to just four RCTs from
outside of the US, representing less than 300 patients with cirrhosis.
To better understand the natural history of the disease and also to further evaluate the use of statins in the
treatment of cirrhosis, the Liver Cirrhosis Network (LCN), consisting of up to 10 clinical centers (CCs) and one
Scientific and Data Coordination Center (SDCC) will be charged with developing (a) a prospective cohort and
(b) an RCT to evaluate statin efficacy in patients with cirrhosis. Northwestern University Data Analysis and
Coordinating Center (NUDACC) and its partners propose to serve as the SDCC--the central scientific and
leadership core for the LCN--coordinating all operational and data-related activities using cutting-edge resources
for study design, planning and conduct, ongoing monitoring, and statistical analyses. NUDACC unites an
interdisciplinary team with wide-ranging experience including collaborative and methodologic biostatisticians,
hepatologists, data managers, project managers, and multiple supporting study staff. Together we propose to
collaborate with the LCN to lead the design, conduct, coordination, oversight, management, administration,
analyses, and dissemination for the LCN-related studies.

Public health relevance
PROJECT NARRATIVE The Northwestern University Data Analysis and Coordinating Center (NUDACC) will serve as a central leadership hub for the Liver Cirrhosis Network (LCN), coordinating all data-related and operational activities using cutting-edge resources for study design, planning and conduct, ongoing data monitoring and statistical analysis. NUDACC will work with National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) and LCN investigators to design (a) a robust, prospective observational cohort study of patients with cirrhosis, and (b) an adaptive, randomized, double-blinded, placebo-controlled trial investigating statin therapy for improvement in overall disease progression. NUDACC will harmonize all aspects of these studies, providing comprehensive oversight, management and administration; implementing state-of-the-art data coordinating; and harnessing methodological and collaborative statistical expertise.